Cancer Center Administration

PROJECT SUMMARY – Cancer Center Administration
Abramson Cancer Center (ACC) Administration is responsible for supporting the ACC, an internationally
renowned, NCI-Designated Comprehensive Cancer Center, in the management of resources and services
required to facilitate the scientific mission of reducing the burden of cancer. These activities include strategic
planning, evaluation, and decision-making; governance and management of the fiscal and administrative
components of multiple ACC- and Cancer Center Support Grant (CCSG)-related activities; and management of
Shared Resources, membership, the CCSG application, research and grant administration, and events and
communication. Administration coordinates with other ACC activities (Community Outreach and Engagement,
and Cancer Research Training and Education Coordination) as well as other support offices in the ACC, such
as: Clinical Protocol and Data Management (CPDM)'s Department of Operations, Compliance and Monitoring;
Development; and the Office of Legal Affairs. It represents the Center within the parent Institution and to the
NCI and other external entities. The challenge of executing these priorities in a complex matrix cancer center
requires Administration to have the talent, experience, and expertise necessary to support multiple constituent
priorities (both internal and external), while maintaining dedication to their mission. ACC Administration
comprises a cohesive group of highly experienced staff with the demonstrated proficiency necessary to
skillfully meet the needs of ACC members, who accomplished unprecedented growth and success in the past
decade. These key administrative staff members have clearly defined roles and responsibilities, with
appropriate reporting lines both internally and within the larger Penn Medicine institution, to ensure that the
administrative activities of the ACC are delivered in an effective and efficient manner. Specific aims are to: 1)
Administratively lead in the governance and decision-making processes of the ACC; 2) Deliver efficient and
effective professional administrative oversight, financial management, and non-administrative and regulatory
guidance to support cancer research activities, including all activities specifically related to the CCSG; and 3)
Represent the interests of the ACC both within the parent Institution and with external groups, to ensure the
Center adheres to, and helps shape, policies that govern its activities.